CRH TEST COMPARED TO ACTH AND ITT IN PATIENTS WITH ADRENOCORTICAL INSUFFICIENCY

Our purpose is to compare the results of the corticotropin releasing hormone (CRH) test to the results of the ACTH and/or insulin tolerance tests in patients with various forms of adrenal insufficiency. We will test the hypothesis that the CRH test is as discriminating a measure of adrenococortical reserve as is the ACTH test in ACTH insufficient individuals and that the CRH test is as specific a measure of pituitary ACTH reserve as is the ITT.